2025 Sex Differences in Immunity Gordon Research Conference and Gordon Research Seminar

SUMMARY
Partial support is requested for a second Gordon Research Conference (GRC) and Gordon Research Seminar
(GRS) on Sex Differences in Immunity. The conference will be held on March 29 – April 4, 2025, at the Four
The Sex Differences
in Immunity GRC/GRS is an international scientific conference focused on advancing the frontiers of science
through the presentation of cutting-edge and unpublished research, prioritizing time for discussion after each
talk and fostering informal interactions among scientists of all career stages. This is the only GRC/GRS
dedicated to sex differences, and the focus on translational immunity, equity and inclusiveness is timely given
growing appreciation that biological sex,
Points Sheraton in Ventura Beach, California, near the Los Angeles International Airport.
meaning the differences between males and females caused by
differential sex chromosome complement, reproductive tissues, and concentrations of sex steroids, impacts the
The conference and seminar
programs include a diverse range of speakers and discussion leaders from institutions and organizations
worldwide, focusing on the latest developments in sex differences in immunity ranging from infectious diseases
and autoimmunity to immuno-metabolism, aging-immunity, and neuro-immunity. The conference is five days
long and held in a remote location to increase the sense of camaraderie and create scientific communities, with
lasting collaborations and friendships. The GRS is a two-day conference that proceeds the GRC and is
dedicated to showcasing and promoting the research of early career scientists (graduate students and post-
docs). In addition to cutting-edge scientific presentations, the GRC/GRS have designated time for poster
sessions from individuals of all career stages, a power hour dedicated to addressing challenges to achieving
equity in science among women and all underrepresented groups, and free time and communal meals to allow
for informal networking with leaders in the field.
functioning of the immune system and disease susceptibility and trajectory.
Through intentional consideration of representation and
inclusion, the 2025 GRC/GRS will promote the involvement of underrepresented minority individuals at all
levels of the meeting. Requested funds will provide partial registration and travel support for invited domestic
and international discussion leaders and speakers as well as for trainees and early-stage investigators. Our
hope is that this conference will contribute to the growth and the nurturing of a new scientific community
engaged in sex differences research to enhance the rigor and the impact of scientific endeavors. We believe
that these goals are aligned with the core mission of the NIH to seek fundamental knowledge about the nature
and behavior of living systems and the application of that knowledge to enhance health, lengthen life, and
reduce illness and disability. In particular, they align well with NIAID’s mission to conducts and supports basic
and applied research to better understand, treat, and prevent infectious, immunologic, and allergic diseases
and NIA’s mission to support research on health and well-being in aging populations.

Public health relevance
NARRATIVE The 2025 Sex Differences in Immunity Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) to be held March 29 – April 5, 2025, at the Four Points Sheraton in Ventura Beach, California will focus on the translation of sex difference in immunity across a wide range of conditions including established and emerging infections, autoimmunity, aging immunity, neuro-immunity, and immune-metabolism. Strategies to bring sex differences research to the mainstream will be discussed by a diverse group of attendees that include trainees, URM, and early and senior scientists with expertise in metabolism, genetics, basic and translation immunology, and data science. The goal is to grow and nurture a diverse community of sex differences researchers to enhance the rigor and impact of biomedical science.